Advanced quantitative analyses of long-read RNA-seq at the bulk and single-cell dimensions

Abstract
Long-read sequencing has been demonstrated powerful for investigating gene isoforms, which could have
critical biomedical roles, such as in embryogenesis, neuroscience and cancer. In the past decade, the Au lab
has been at the forefront of developing novel bioinformatics software for identifying complex gene isoforms in
different perspectives and have delivered many new transcriptomics insights at the gene isoform level via the
applications to stem cells and cancer. Beyond the development of 8 long-read RNA-seq software, the Au lab
also published 4 papers for establishing the corresponding data collection and analysis guidelines. In
particular, the Au lab is one of the primary organizers of the US-Europe consortium “Long-read RNA-seq
Genome Annotation Assessment Project (LRGASP)” for evaluating the effectiveness and the methodology of
long-read RNA-seq. In total, the Au lab as the primary authors has published 14 papers focusing on long-read
sequencing with >4,800 citations.
Beyond the existing qualitative analyses and basic quantification, the greatly improved yield of long-read
sequencing makes advanced quantitative analyses with long-read RNA-seq possible, which will be of wide
utility towards studying gene isoforms in depth. Especially, with bulk data, comparative analysis of gene
isoform abundance can find the meaningful biomedical differences; with single-cell data, cell clustering at the
gene isoform level has potential to find new cell types that have been masked by gene-level analysis in the
past. Indeed, the prevalence of fruitful studies of alternative splicing has indicated the great potential of the
gene isoform-level analysis in delivering biomedical discovery.
The Au lab’s accumulating expertise in the field is well-suited to establish the methodological foundation of this
goal in this funding cycle. Our previous studies have shown that varying quantification error exists in gene
isoform quantification, which depends on gene isoform structure complexity and data. To tackle this varying
error in the advanced quantitative analyses, we will develop a set of bioinformatics methods using read count
as direct input to represent gene isoform profile. Our proposed methods will allow discovery of differential
expressed isoforms, allele bias at isoforms and isoform switching with statistical significance from bulk long-
read RNA-seq; and allow discovery of new cell types with unique gene isoform expression from long-read
single-cell RNA-seq. In parallel, we will establish the corresponding guideline for data collection and analysis
as we did in the first wave of long-read RNA-seq bioinformatics in the past decade. We will apply these
methods to our own data and the publicly available data from multiple consortia for investigating gene isoforms
quantitatively at stem cells, neuroscience and other broad biomedical contexts.

Public health relevance
PROJECT NARRATIVE / PUBLIC HEALTH RELEVANCE STATEMENT To fully utilize the rapidly improving long-read sequencing, we propose to develop innovative bioinformatics software for advanced quantitative analyses of transcriptome beyond the existing focus on qualitative analyses. We will also carry out extensive benchmarking as well as data science study to establish a guideline of data collection and analysis for the community to use the techniques and data in a rigorous and optimal way. In particular, we will focus on the comparative expression analyses and single-cell analyses of long-read RNA- seq at the gene isoform level so that we can find the subtle but meaningful difference of isoform expression that were masked by the previous studies at the gene level but were extensively suggested by the fruitful studies of alternative splicing in a wide spectrum of biomedical contexts.